Enrichment Program

PROJECT SUMMARY The Center for Iron and Heme Disorders (CIHD) will provide a vehicle to expand the research base in the field of non-malignant hematology, namely the Enrichment Program. This will be accomplished by providing training opportunities for each of the proposed biomedical core facilities. This is designed to promote collaboration by educating the broader academic community in the use of these highly specialized technologies. Integration of the CIHD with existing training programs in hematology, genetics and translational medicine will attract new investigators to the field. Collaboration with other NIDDK-funded Cooperative Hematology Specialized Core Centers to leverage successful programs and share technologies will provide a network of services to promote both basic and translational science. Program staff will organize academic workshops to provide mentoring opportunities for junior faculty and post-doctoral fellows. The Enrichment Program will enhance existing programs at the University of Utah by expanding the research base and providing a mechanism to form both formal and informal collaborations. Exchange programs for visiting scientists wanting to learn techniques available through the proposed cores will be managed by this component of the CIHD. The overarching goal of the Enrichment Program is to expand opportunities for new investigators in the field of non-malignant hematology by providing education, exchange programs, and stimulating scientific programs in the areas of iron metabolism and heme biosynthesis.